Linking Inter-professional Newborn and Contraception Care (LINCC) Trial - A Novel Approach to Postpartum Contraception Provision at the Well-Baby Visit

PROJECT SUMMARY/ABSTRACT
Pregnancies conceived within 18 months of a prior delivery (termed short inter-pregnancy interval [IPI]) place
mothers and infants at high risk for poor health outcomes including pre-eclampsia, anemia, and preterm birth.
Despite these negative health consequences, nearly one third of women experience a short IPI, highlighting a
significant public health problem in the U.S.
A critical approach to preventing short IPIs is to provide postpartum (PP) women with timely access to
contraception. The current standard clinical practice is to have women return six weeks after delivery for a
postpartum visit, at which time contraceptive needs are addressed. However, many women resume sexual
activity prior to six weeks PP, and many women, particularly low-income minority women, do not present for
this visit. Low rates of postpartum contraception uptake leave women vulnerable to an unplanned pregnancy
and significant negative health consequences. Thus, there is an urgent need for alternative approaches to
increase timely access to PP contraception to improve outcomes for women and children.
The proposed study aims to: (1) develop a comprehensive implementation plan to link PP contraception and
newborn care through co-scheduling visits in community health centers (CHC) and (2) use an effectiveness-
implementation hybrid design to evaluate this novel system-level approach to linking maternal and newborn
care at CHCs served by our partner organization, AllianceChicago. Lastly, we aim to: (3) assess
implementation of linked PP contraception and newborn care and report on key barriers and facilitators related
to successful implementation of the intervention.
Increasing access to timely contraception is a promising strategy to help women plan their families and, in turn,
reduce the poor health sequela associated with short IPI pregnancies. The long-term impact of this study is to
reduce negative health outcomes among PP women and infants by increasing access to patient-oriented PP
contraceptive care. Findings may provide evidence supporting a paradigm shift for linked PP care and identify
important insights to facilitate successful implementation of this model of care in CHCs across the nation.

Public health relevance
PROJECT NARRATIVE Pregnancies conceived within 18 months of a prior delivery (termed short inter-pregnancy interval [IPI]) place mothers and infants at high risk for poor health outcomes and affect nearly one third of women in the U.S. Rates of postpartum (PP) contraception use remain low, particularly among low-income minority women, leading to high rates of short IPI pregnancies. This proposed study aims to address the gap in the current model of PP contraception care, by developing and implementing a novel approach to link (co-schedule) PP contraception care with newborn well-baby care with the goal of improving access to timely PP contraception.